Sex-dependent regulation of cardiac cAMP, ECC, and arrhythmia by phosphodiesterases

Abstract
Autonomic dysregulation and aberrant intracellular signaling are hallmarks of both heart failure with reduced
ejection fraction (HFrEF) and heart failure with preserved ejection fraction (HFpEF). Cyclic AMP (cAMP) is a key
second messenger that transduces extracellular autonomic adrenergic signals to control downstream
contractility and electrophysiology on a beat-to-beat basis. Aberrant cAMP signaling likely plays an important
role in Ca2+ mishandling, contractile dysfunction, and arrhythmias in HF. cAMP is highly compartmentalized by
b-adrenoceptor (b-AR)-induced cAMP synthesis and phosphodiesterase (PDE)-mediated degradation. The
overall goal of this project is to determine the differential role of heterogeneous PDE4D signaling in contributing
to dysfunctional excitation-contraction coupling (ECC) and arrhythmias in HFpEF vs. HFrEF in a sex-dependent
manner. The main hypothesis that will be tested in this project is that either too much or too little PDE activity
in cardiomyocytes can impair ECC and promote arrhythmias, and that underlying sex differences in PDE activity
modulate sex-dependent responses. Using a novel integrated whole-heart imaging approach combined with
single cell analysis and detailed subcellular signaling studies and FRET-based reporters, we will
comprehensively determine signaling responses and functional outcomes from the molecular, cellular, to whole-
heart level, which may ultimately suggest more personalized treatment strategies for men and women with HF.

Public health relevance
Narrative and Public Health Relevance Heart failure with preserved ejection fraction (HFpEF) is a distinct disease compared to heart failure with reduced ejection fraction (HFrEF), which is the leading cause of mortality in the United States. We aim to determine how phosphodiesterases regulate cAMP signaling to impact functional excitation-contraction coupling and arrhythmia in HFpEF vs. HFrEF in a sex-dependent manner. This study may offer more personalized treatment strategies for men and women with HFpEF.